Project 3 - Modulation of Antiviral Immunity and T cell Exhaustion by Inhibitory Receptors

CD8+ T cell exhaustion is central to chronic infections, cancer, and autoimmunity. High expression of the
inhibitory receptors (IR) PD1 and LAG3 is a central feature of exhausted CD8+ T cells (Tex), and these IRs have
emerged as major clinical targets. Nevertheless, not all patients treated with IR targeting therapies have durable
benefit, and the molecular mechanisms connecting PD1 and LAG3 to downstream changes in CD8+ T cell
differentiation and function are unclear. Indeed, there are fundamental gaps in knowledge about how these IRs
control antiviral CD8+ T cells. These gaps include defining the role of these IRs on different subsets of antiviral
CD8 T cells, discovering how synergy between PD1 and LAG3 functions, and determining how PD1 and LAG3
regulate chimeric antigen receptor (CAR) T cells compared to conventional T cells given the distinct architecture
of a CAR versus a T cell receptor. Moreover, most data that exist on how PD1 and LAG3 control antiviral CD8
T cell biology in vivo are generated several weeks after loss-of-function and the early primary molecular circuits
remain unknown. Moreover, we lack understanding of which of these changes associated with PD1 and/or LAG3
loss-of-function are causal. Project 3 will address these questions for antiviral CD8+ T cells. Thus, our central
hypothesis is that PD1 and LAG3 engage distinct proximal molecular circuits in different subsets of antiviral
effector-phase CD8+ T cells and, during established chronic infection, Tex cells and that testing causality of these
changes will reveal new mechanisms by which these IRs control antiviral CD8+ T cell biology.
AIM 1: What causal circuits downstream of PD1 and/or LAG3 control subsets of antiviral effector-phase
CD8+ T cells during the first week of acute or chronic infection? PD1/LAG3 are expressed by different
subsets of antiviral effector-phase CD8+ T cells. Yet the molecular mechanisms by which these IRs, separately
or together, contribute to differentiation, function, and downstream lineage development are unknown. We
hypothesize that applying transcriptionally guided, focused CRISPR screens will define the causal circuits and
mechanisms underlying the role of PD1/LAG3 on different subsets of effector phase antiviral CD8+ T cells.
AIM 2: What causal circuits downstream of PD1 and/or LAG3 control subsets of antiviral CD8+ Tex cells?
Preliminary data reveal distinct, proximal transcriptional circuits engaged by PD1 pathway blockade for the three
main Tex subsets: TexProg, TexInt, and TexTerm, yet the causality and downstream mechanisms are unknown. We will
test the hypothesis that casual pathways and molecular mechanisms of PD1/LAG3 and their synergy for different
subsets of Tex will be discovered using transcriptionally guided, focused CRISPR screens and cellular lineage
tracing experiments.
IR-PPG Interactions: Since the central molecular program of exhaustion is conserved in chronic viral infections,
tumors, and autoimmunity, P3 will connect extensively with P1 and P2 and extensively used Cores A-D to dissect
the nature of T cell exhaustion and the role of PD1/LAG3 across diseases.
.

Public health relevance
Project Narrative Chronic infections with viruses such as HIV, HCV and HBV affect half a billion people and are significant causes of morbidity and mortality. T cell dysfunction or “exhaustion” is a major immunological defect during these infections and can be modeled with LCMV infection in mice. The studies proposed will define the role of the inhibitory receptors PD1 and LAG3 in CD8+ T cell exhaustion and provide new insights into how to reverse and avoid T cell exhaustion and improve immunity during these and other chronic infections.